La Spada Outstanding Investigator Award

Abstract
I have been studying neurodegenerative disease for more than 30 years. While a graduate student, I identified
the cause of X-linked spinal and bulbar muscular atrophy (SBMA) as the expansion of a CAG repeat in the
androgen receptor (AR) gene. As the first disorder shown to be caused by a CAG – polyglutamine
(polyQ) repeat tract, this discovery led to the emergence of a new field. My research program began with
emphasis on 2 polyQ disorders: SBMA and spinocerebellar ataxia type 7 (SCA7). My early work established
transcription dysregulation as a key factor in polyQ disease pathogenesis. I initiated research on Huntington’s
disease (HD), and linked mitochondrial dysfunction and metabolic deficits in HD to transcription dysregulation
of PGC-1a, a transcription co-activator. In 2016, I documented an interaction between PPARd and huntingtin
(htt) protein in striatal-like neurons and in the cerebral cortex of HD mice, and I demonstrated that PPARd
repression contributes to HD neurotoxicity. These findings led me to repurpose a selective and potent PPARd
agonist, KD3010, as capable of rescuing htt neurotoxicity in HD transgenic mice and in medium spiny neurons
from HD patient stem cells. Concomitant with my HD research, I uncovered a central role for skeletal muscle
in SBMA by demonstrating that excision of mutant AR transgene from skeletal muscle in BAC conditional
transgenic mice prevented the development of neuromuscular SBMA phenotypes, establishing the importance
of skeletal muscle – motor neuron (MN) communication at the neuromuscular junction (NMJ) for SBMA lower
MN disease. I have thus continuously maintained NINDS R01 funding to support my SBMA research since
2000, and have held NINDS R01 funding to support my HD research since 2010. During this time frame, my
research has increasingly focused on identification of targets and pathways for development of therapies. As a
R35 recipient, I will continue my research on the cellular and molecular basis of polyQ neurodegeneration,
embracing opportunities to extend our findings to more common neurodegenerative diseases, including AD,
PD, and ALS. One major focus will be to define the basis of SBMA muscle-driven MN disease through skeletal
muscle and NMJ transcriptome analysis of SBMA model mice and stem cell modeling to recapitulate non-cell
autonomous SBMA MN degeneration. I also intend to pursue studies of HD and PPARd by determining the
normal function of PPARd in CNS and defining how PPARd activation achieves neuroprotection. I will follow
up on exciting findings linking PPARd neuroprotection to regulation of neuronal activity-dependent gene
expression, and will test if blunting of rapid primary response gene expression can ameliorate HD phenotypes.
As PPARd is highly expressed in microglia and represses neuroinflammation, I will study PPARd function in
microglia and test if PPARd dysregulation plays a role in neurodegenerative disease. R35 funding would
provide me with the flexibility to pursue novel, ambitious studies of polyQ disease, expand my research
program to encompass emerging areas of pathogenesis, and maintain a lasting commitment to translational
research and therapy development for neurodegeneration.

Public health relevance
Project Narrative My academic research career in the field of neurodegenerative disease spans 30 years, beginning with my discovery of the first CAG – polyglutamine repeat expansion as the cause of an inherited neurological disorder, extending to 22 years as an independent investigator who has worked primarily on three polyglutamine repeat diseases (X-linked spinal & bulbar muscular atrophy [SBMA]; spinocerebellar ataxia type 7 [SCA7]; and Huntington’s disease [HD]), and including 20 years of continuous R01 funding from NINDS, with two currently active R01 grants. I have recently published a number of significant papers that advanced our understanding of these disorders, demonstrating skeletal muscle expression of mutant androgen receptor as a primary driver of SBMA motor neuron disease in a series of independent studies, documenting PPARd dysfunction in HD pathogenesis, confirming a role for PPARd in normal CNS function, and establishing PPARd agonist therapy as a potential HD treatment. I now request funding through the Outstanding Investigator Award mechanism to continue my dynamic and wide-ranging investigations into the cellular and molecular basis of polyglutamine neurodegeneration, as I seek to define the molecular basis of SBMA skeletal muscle-driven motor neuron degeneration, delineate how PPARd activation achieves neuroprotection, determine if processes of NMJ dysfunction or overexuberant activity-dependent gene expression may be relevant to more common neurodegenerative diseases, including ALS and AD, and seek to develop novel therapies that will restore homeostasis pathways that decline in function with aging and are markedly diminished in neurodegeneration.